Administrative Core

The Administrative Core has a central role in coordinating the functions of the Pittsburgh Center
for Kidney Research, a George M. O'Brien Kidney National Resource Center (NRC). Dr.
Thomas Kleyman is the Administrative Core Director, and Dr. Ora Weisz is the Associate Core
Director. Together they are responsible for the scientific and administrative operations of the
Administrative Core. Drs. Kleyman and Weisz will (i) provide leadership in the management of
Pittsburgh’s NRC, (ii) monitor the utilization, prioritization, quality control, and effective and
efficient operation of the research Cores, (iii) closely collaborate with the National Coordinating
Center (NCC), the National Steering Committee, NIDDK program leadership and other NRCs to
enhance national outreach and ensure broad and robust utilization of the Core facilities by
investigators across the US, (iv) work with the Core Directors to incorporate new
technologies/methodologies into our Center Cores, (v) work to attract early-stage and
established investigators new to kidney research, (vi) facilitate information transfer within
Pittsburgh’s NRC, the NCC, the national scientific community and the local lay community, (vii)
work to increase diversity within Pittsburgh’s NRC, and (viii) coordinate and administer lay
education and summer student enrichment programs. The Administrative Core will also prepare
progress reports and oversee the production and distribution of regular budget reports to the
Core Directors.